Clinical Research on Nonalcoholic Fatty Liver Disease

PROJECT SUMMARY
Metabolic dysfunction-associated steatotic liver disease (MASLD), formerly termed nonalcoholic fatty liver
disease (NAFLD), affects approximately 25% of adults and 10% of children in the United States. Multi-factorial
in its pathogenesis, the clinical/histologic spectrum of MASLD encompasses steatosis, metabolic dysfunction-
associated steatohepatitis (MASH), variable degrees of fibrosis, and cirrhosis. The presence of MASH or
advanced fibrosis due to MASLD are associated with increased risks of hepatic decompensation, hepatocellular
carcinoma (HCC), and death. There are currently no FDA-approved therapies for treatment of MASH. The sheer
scale of the affected population creates an urgent need for effective treatments as well as non-invasive modalities
and biomarkers that alone or in combination accurately 1) predict who is at high risk for disease progression in
the MASLD population, 2) detect and stage MASLD, MASH, and liver fibrosis, 3) predict treatment response, as
determined by ≥ 1-stage improvement in fibrosis or MASH resolution.
Since its inception in 2002, the NASH CRN has worked collaboratively to characterize the natural history of
MASLD, define its pathogenesis, and develop superior diagnostics and effective treatments. During the past
funding cycle (2018-23), the CRN completed recruitment for the longitudinal adult and pediatric Database 2
registry (N=3,068) and the STOP-NAFLD trial (N=83). In addition, it initiated two studies: 1) Database 3, a
longitudinal study of the etiology, natural history, diagnosis, treatment and prevention of MASLD and MASH with
a goal of recruiting a diverse cohort, and 2) the Vitamin E Dosing Study (VEDS), a clinical trial with the primary
aim of determining the minimum effective dose of Vitamin E for MASH.
The NASH CRN’s highly characterized cohorts, including more than 700,000 biospecimens in the NIDDK
repository, together with the investigator’s expertise in leveraging public-private partnerships, has allowed us to
perform innovative clinical trials and pursuits in diagnostic development and validation that can only be
addressed by engaging in a coordinated, longitudinal, comprehensive research consortium. The overriding
primary objective of the NASH CRN continues to be clinical research on MASLD in children and adults. A
secondary objective of high priority is to conduct translational research in MASH and MASLD and to develop
superior diagnostics and treatments, with a focus on diagnostics that are non-invasive and treatments that are
safe, affordable, effective and readily available.
The specific aims proposed to achieve these objectives from the UCSD Clinical Center during the continuation
of the NASH CRN are to 1) complete the Database 3 Study, 2) complete the VEDS Study, and 3) validate and
advance development of novel non-invasive biomarkers for MASH, at-risk MASH, and advanced fibrosis or
cirrhosis.

Public health relevance
PROJECT NARRATIVE The Nonalcoholic Steatohepatitis Clinical Research Network (NASH CRN) is a consortium of clinical centers and a Data Coordinating Center studying the cause and treatment of MASH, formerly termed NASH, in order to prevent known outcomes of cirrhosis, liver transplant and liver cancer. Our studies have identified noninvasive measures for diagnosis, prognosis and prevention of disease. Our center aims to continue being the major site for the completion of major studies and have enrolled the largest number of children and minorities in the Network.